COBRE in Digestive and Liver Disease

Overall – Project Summary
The overall goal of the Center of Biomedical Research Excellence (COBRE) in Digestive & Liver Disease (CDLD)
is to enable outstanding multidisciplinary collaborative research in digestive and liver diseases at the Medical
University of South Carolina. These diseases are of importance to the state of South Carolina because of the
tremendous, disparate burden they have upon the state’s citizens. The specific aims are to: 1) Mentor, train,
recruit and retain a cadre of early career scientists to become independently funded investigators in digestive
and liver disease research; 2) Develop sustainable scientific core resources to support digestive and liver
disease studies while leveraging institutional investments; and 3) Promote the long-term viability and success of
the CDLD through development of multidisciplinary basic science research programs, rigorous evaluation,
ongoing improvement strategies, and mission alignment with other centers at MUSC. The Center is led by a
multidisciplinary team of leadership within the MUSC College of Medicine, coalescing resources to achieve their
overarching objective of building a critical mass of funded investigators that will allow MUSC to compete for
future external peer-reviewed programmatic grant support. This application highlights four of our most
outstanding Research Project Leaders (RPLs) who will benefit from an innovative multiple source mentoring plan
which features both internal and external mentors. Based on the success of our Phase 1 RPLs, we anticipate
Phase 2 RPLs to transition to independent NIH funding within the first three years of the project. The CDLD also
includes three Cores that support not only the RPLs but also digestive and liver disease investigators throughout
the medical center. Scientific cores include the: 1) Cell Models Core, which will generate advanced cell models
of digestive and liver diseases; 2) Animal Models of Digestive Disease Core, which will provide access to and
training in essential animal models; and 3) Advanced Imaging Core, delivering sophisticated equipment,
technologies and expertise required for successful, state-of-the-art cell and tissue-based imaging and analysis.
Additionally, the CDLD will continue to foster collaborations among digestive and liver disease researchers by
promoting interdisciplinary scientific exchange through our enrichment activities and build research capabilities
through our Pilot Project Program. With NIH and institutional support, the CDLD will attain our long-term goal of
integrating basic, translational and clinical research as a sustainable, multidisciplinary, programmatic center.

Public health relevance
Overall – Project Narrative Digestive and liver disease bears a significant impact in the United States with nearly 70 million US citizens per year impacted by a GI- or liver-related disorder in 2022. Based upon the existing strengths at MUSC and their importance to digestive and liver disease, the CDLD will support research in four thematic areas: 1) Cell Injury, 2) Inflammation and Fibrosis, 3) End Organ Disease, and 4) Cancer. The CDLD will expand these research themes at MUSC by unifying multidisciplinary digestive and liver disease investigators, providing mentoring, and equipping investigators with access and training in advanced technologies and models of digestive disease.